Core C- BIDMC Core

SUMMARY
The proposed multi-disciplinary Program Project Grant (PPG) will utilize interdisciplinary expertise, key
established resources, cutting-edge technologies, and extensive in vivo and human studies to bypass
substantial roadblocks in our understanding, management, and treatment of lupus nephritis (LN). Core C will
leverage already established extensive resources, specialized personnel, infrastructure, and expertise to
address effectively and efficiently sample processing, data generation, ingestion, and integration, major
bottlenecks in spatial/single cell profiling. Core C will prioritize data provenance and best practices,
ascertaining that all activities adhere to the FAIR principles across the data life cycle. Core C will ensure
streamlined data generation, acquisition, quality control, management, and provenance across the PPG,
achieved through 3 distinct aims: the generation of production-grade highly automated single cell and spatial
tissue profiling data (Aim 1), the establishment of streamlined data processing, quality control, management,
and provenance (Aim 2); and the promotion of best practice, scalable, multi-modal data processing, analysis,
and integration (Aim 3).
The Core will work closely with the personnel of the Administrative Core, the Cores, and the Projects for
efficient and timely data delivery. The rich metadata captured across all activities, along with versions, code,
and extensive provenance activities, will ascertain that all datapoints adhere to the FAIR principles. By
centralizing high throughput assay performance, bioinformatics, and biostatistics the Core enables uniform
best practice analyses across all activities, effective data integration, seamless reuse, interoperability, and
cost-effectiveness.
All pipelines and protocols will be shared to facilitate the community to recreate findings and build upon this
effort. Wherever possible, pipelines will be provided as complete workflows or containers for easy deployment
in diverse environments. We will build upon our experience of implementing production grade assays and
impactful bioinformatics/data resources that are trusted by researchers worldwide.

Public health relevance
NARRATIVE Core C will ensure streamlined data generation, acquisition, quality control, management, and provenance across the PPG. It will generate production-grade highly automated single cell and spatial tissue profiling data; establish streamlined data processing, quality control, management, and provenance; as well as promote best practice, scalable, multi-modal data processing, analysis, and integration. Core C will work closely with the personnel of the Administrative Core, the Cores, and the Projects for efficient and timely data delivery.